Mechanisms and parameters controlling gene amplification leading to phenotypic heterogeneity in Enterobacter

PROJECT SUMMARY
Antibiotic resistance is a growing global crisis exacerbated by a dearth of novel antibiotic classes and the
rapid emergence of resistance to novel antibiotics of existing classes. In the United States, nearly 1 in 7
deaths attributed to bacterial pathogens are caused by Enterobacter or Klebsiella pneumoniae, members
of the order Enterobacterales with among the highest rates of cephalosporin-and carbapenem-resistance.
One form of antibiotic resistance is heteroresistance, a type of phenotypic heterogeneity in which an
isolate harbor a minority resistant subpopulation within a majority susceptible population. The resistant
subpopulation is dynamic: unlike other resistant subpopulations which include persisted and tolerant cells,
the heteroresistant subpopulation grows during antibiotic exposure and becomes the majority population
as the susceptible cells are killed but will return to baseline frequency when antibiotic exposure ends.
Thus, this transient, low frequency resistant subpopulation is challenging to detect clinically and may be a
cause of unexplained treatment failure. Experiments aimed to understand the mechanistic basis for
heteroresistance to the novel cephalosporin cefiderocol revealed that many Gram-negative isolates harbor
resistant subpopulations that encode many copies of an extended-spectrum beta-lactamase gene. The
primary focus of preliminary experiments, Enterobacter isolate RS, encodes the blaSHV-5 beta-lactamase
in a region flanked by identical sequences. This region undergoes homology-mediated gene amplification,
creating the resistant subpopulation. While the subpopulation is resistant to cefiderocol and other
cephalosporins because of the multiple copies of blaSHV-5, the underlying principles which result in
multiple copies are unknown. To characterize these principles of amplification, experiments proposed here
will in Aim 1 define the factors governing homology-mediated amplification in the Enterobacter
chromosome, focused on understanding how the size and content of the amplified region, and the
homologous sequences, influence gene amplification and subpopulation dynamics in vitro and during
murine models of antibiotic therapy. Additional experiments identified that the activity of the SHV-5
enzyme dictates the extent of amplification. Chemical or genetic inhibition of SHV-5 activity resulted in
greater gene copy number in the resistant subpopulation, establishing a connection between enzyme
activity and subpopulation dynamics. Thus, experiments in Aim 2 will determine the effects of beta-
lactamase activity on gene amplification and subpopulation dynamics in Enterobacter and K. pneumoniae
in vitro and in vivo. Findings from this work will describe the factors governing gene amplification and
provide insight into diverse forms of phenotypic heterogeneity that result from gene amplification, as well
as enhance our understanding of the dynamics between resistant subpopulations and antibiotic treatment.

Public health relevance
PROJECT NARRATIVE Antibiotic resistance is a public health crisis because antibiotics fail to cure infections. Heteroresistance is a type of antibiotic resistance that is hard to detect but prevalent, and likely contributes to antibiotic treatment failure. Results of the proposed experiments will enhance our understanding of antibiotic resistance by discovering the mechanisms which result in heteroresistance and antibiotic treatment failure, improving our ability to predict heteroresistance and treatment outcomes.